Collagen Diversity and Pathobiology in Skeletal Tissues

DESCRIPTION (provided by applicant): In this competing renewal of AR036794 (title updated to reflect the evolution in specific aims and scope), we focus on a newly discovered mechanism of regulation of collagen fibril diversity that is important for understanding skeletal tissue differentiation and pathobiology. We have evidence that 3-hydroxproline (3Hyp) residues play a fundamental role in directing the manner of fibrillar collagen supramolecular assembly. The first hint came from our demonstration by mass spectrometry that the single, fully occupied 3Hyp site (P986) near the C-terminus of collagen a1(I) and a1(II) chains fails to be hydroxylated in collagens of the crtap mouse and recessive forms of human osteogenesis imperfecta (O.I.) caused by CRTAP or LEPRE1 mutations. We now have evidence for three classes of 3Hyp site in fibril-forming collagens. For example, a second site in type II collagen is highly hydroxylated in vitreous, meniscus and intervertebral disc but not in hyaline cartilage. The sequence motif of this second site is reproduced at D-periodic intervals in a2(V), with 3Hyp present, and shows similarities to a 3Hyp motif in type IV collagen. Tendon collagen uniquely contains a third type of 3Hyp motif, which we believe is characteristic and functionally important in tendon, ligament and related highly tensile tissues. Under 4 aims, we intend to pursue this concept aggressively since it is central to understanding how different cell types regulate the diversity of heteropolymeric collagen assemblies between different cartilages, bone, tendon and other connective tissues. If correct, it also has concept- changing implications for the field of vertebrate collagen biology. The clinical significance is in providing a molecular basis for understanding processes that cause cartilages and other collagenous tissues of low turnover to degenerate in the adult musculoskeleton in osteoarthritis, disc degeneration and related disorders of collagen framework failure. In addition, a full understanding of the effects of disrupting prolyl 3-hydroxylation in recessive forms of osteogenesis imperfecta we believe will reveal a molecular mechanism for brittle bone common to all forms of O.I. Such findings will also be significant for understanding qualitative changes in bone matrix that add significant risk of osteoporotic fracture in the population as a whole and a potential for novel biomarkers and therapeutic targets.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal is to understand molecular mechanisms that govern the diversity in properties of collagen, the protein that forms the structural framework of all major skeletal tissues in the body including bone, cartilages, tendons and ligaments. Specifically, we aim to define the biochemical pathways that equip bone collagen to mineralize, cartilage to last a lifetime as the bearing surfaces of joints and tendons and ligaments to transmit or restrain high mechanical loads without failing. With this knowledge new targets for therapy and prevention of genetic and acquired human disorders of bones and joints are predicted. Project Narrative The goal is to understand molecular mechanisms that govern the diversity in properties of collagen, the protein that forms the structural framework of all major skeletal tissues in the body including bone, cartilages, tendons and ligaments. Specifically, we aim to define the biochemical pathways that equip bone collagen to mineralize, cartilage to last a lifetime as the bearing surfaces of joints and tendons and ligaments to transmit or restrain high mechanical loads without failing. With this knowledge new targets for therapy and prevention of genetic and acquired human disorders of bones and joints are predicted. __SpecificAimsTextDelimiter__ A. Specific Aims In this renewal proposal we pursue a driving hypothesis that prolyl 3-hydroxylation is a pivotal post-translational modification of collagen and when defective a significant cause of skeletal disease. In past work, we revealed the unique cross-linking function of type IX collagen and variable chain compositions of the collagen type V/XI template as factors in cartilage pathobiology. We now concentrate on post-translational differences within and between collagen types, which also dictate functional differences in fibril architecture, for example through cell-specific controls of lysyl hydroxylase activities. Prolyl 3-hydroxylases were recently shown to be significant players. In studies on the Crtap-/- mouse, in collaboration with Brendan Lee's lab, we showed by mass spectrometry that 3Hyp was missing from P986 in crtap-/- collagens. This led to the discovery of mutations in CRTAP, LEPRE1 and other genes of the P3H1 complex and ER chaperones as a cause of recessive forms of human O.I. To help determine if 3Hyp has a direct function in extracellular collagen fibrils, we mapped 3Hyp in A-clade and B-clade chains of bovine and human tissue collagens. Unexpectedly the results showed D-periodic spacing between a series of previously undescribed partially 3-hydroxylated prolines in A-clade and B-clade collagen chains in addition to the full P986 hydroxylation site. Mammalian type III collagen was an exception, with no 3Hyp. It is notable that collagen III forms polymers with the surface of collagens I and II fibrils rather than independent polymers. Finally we very recently discovered a third class of serial 3Hyp residues at the C-terminus of tendon, but not skin or bone, type I collagen, with strong evidence that this post-translational modification is linked to subsequent polymeric assembly. In summary, our goal is to test a hypothesis that prolyl 3-hydroxylation, an ancient modification that arose in the most primitive collagens, further evolved and diversified in vertebrates as collagen genes and the responsible enzyme complexes underwent genome duplications and sequence drift. Aims 1. Complete the molecular map of prolyl 3-hydroxylation sites in different collagen types of normal skeletal tissues in conjunction with ongoing collaborations to understand how recessive mutations affect this complex pathway and cause recessive O.I./skeletal dysplasia phenotypes. Hypotheses tested: Three substrate classes of 3Hyp modification are present in mammalian collagens. Mutations that cause O.I.-like phenotypes will differentially affect these sites in a manner dependent on the gene defect. A unifying mechanism of O.I. pathogenesis will emerge. 2. Define the scope of class 3 3Hyp modifications ((GPP)3-5 repeat) across collagen types and tissue types with emphasis on the musculoskeleton. Relate to a phylogenetic origin. Hypotheses tested: The class 3 substrate motif is ancient, occurs along with class 2 sites in type IV collagen, and has 'evolved' to tailor certain fibrillar collagens for high tensile functions. 3. Seek protein-binding partners for all three classes of 3Hyp motif from inter-triple-helical bonding to candidate fibril-associated proteins including SLRPs and matrilins. Hypotheses tested: All three classes of 3Hyp motif function as a source of hydrogen-bonded interaction between triple-helices and also, potentially as binding sites for, fibril-associated proteins known to be involved in the assembly and mature function of fibrils. 4. Pursue the significance of the absence of 3Hyp in type III collagen Hypotheses tested: Collagen III either lost a functional need for 3Hyp in vertebrates, or mammals differ from birds, amphibians and reptiles in collagen III polymeric properties.